HIV, HCV and Liver Disease Among Injection Drug Users in Chennai, India

DESCRIPTION (provided by applicant): Proposed is an application in response to PA-09-020, International Research Collaboration on Drug Addiction. that brings together Johns Hopkins University and the YR Gaitonde Centre for AIDS Research and Education to characterize interactions between HIV, hepatitis C virus (HCV), tuberculosis (TB), alcohol and liver disease among injection drug users (IDUs) in Chennai, India and to inform future treatment initiatives and interventions to reduce the burden of liver disease in a population with a confluence of hepatotoxic factors. In the developed world, liver disease has emerged as a leading cause of morbidity among HIV-infected IDUs. However, little work has been done in developing countries which represent the fastest growing HIV epidemics among IDUs. HCV treatment is not widely available in the developing world; however this disparity will change raising the urgency of understanding how exposures unique to India affect prevalence and forms of liver disease and whether those at greatest risk can be identified with novel, culturally acceptable tools. Accordingly, our aims are: AIM 1: To ascertain the prevalence of fatty liver disease (e.g., steatosis, steatohepatitis) and investigate the hypothesis d4T use, HCV genotype 3, insulin resistance and alcohol use are independently associated; AIM 1.1: To validate existing diagnostic algorithms for steatosis and fibrosis and to compare the predictive accuracy of existing panels (e.g., APRI, FIB-4) with new panels that use low-cost tests and local risk factors; AIM 2: To determine whether steatosis and liver fibrosis impact the incidence of future hepatic adverse events associated with antiretroviral therapy (ART) and anti-tuberculosis therapy (ATT); AIM 3: To begin to pilot interventions to reduce the burden of liver disease among IDUs in India; AIM 3.1. To quantify the acceptability and potential for HCV treatment response (prevalence of single nucleotide polymorphisms [SNPs] in the IL28b gene) among IDUs in India; and AIM 3.2. To conduct a double-blinded placebo controlled randomized clinical trial to determine the efficacy of Vitamin E for the treatment of steatosis. We will achieve these aims through a mix of cross-sectional studies, longitudinal cohort follow-up and a double-blinded placebo controlled randomized clinical trial building on two existing cohorts. For Aim 1, we will use ultrasonography for steatosis and Fibroscan(R) for fibrosis. For Aim 2, we will follow persons semi-annually to identify new initiates of ART and ATT and conduct intensive follow-up after initiation to determine hepatic tolerability. In Aim 3, we will assess acceptability of HCV treatment via questionnaire and potential treatment response via host genetic testing. The Aim 3 trial will be conducted among 100 IDUs with histologic steatohepatitis at baseline. We have a small window of opportunity to prepare for the impending epidemic of liver disease among IDUs in the developing world. These findings will also inform donors such as PEPFAR and GFATM regarding treatment decisions as the prevalence of HIV-HCV co-infection continues to rise as a result of the increasing contribution of injection drug use to the HIV epidemic in the developing countries including Africa.

Public health relevance
PUBLIC HEALTH RELEVANCE: Injection drug users (IDUs) are at high risk for HIV and hepatitis infections and the long-term complications of these infections, including liver disease, drug-related hepatotoxicity and mortality. The findings from this study will help to inform interventions to reduce the morbidity and mortality associated with drug use, HIV and hepatitis C. to inform interventions to reduce the morbidity and mortality associated with drug use, HIV and hepatitis C. Relevance Injection drug users (IDUs) are at high risk for HIV and hepatitis infections and the long-term complications of these infections, including liver disease, drug-related hepatotoxicity and mortality. The findings from this study will help to inform interventions to reduce the morbidity and mortality associated with drug use, HIV and hepatitis C. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS In response to the Program Announcement: PA-09-020, "International Research Collaboration on Drug Addiction," this application brings together scientists from Johns Hopkins University (JHU), USA, and the YR Gaitonde Centre for AIDS Research and Education (YRGCARE), Chennai, India to characterize the interactions between HIV, hepatitis C virus (HCV), tuberculosis (TB), alcohol and liver disease in a population of injection drug users in Chennai, India and to help inform future treatment initiatives and interventions to reduce the burden of liver disease in this population with a confluence of hepatotoxic factors. In the developed world, liver disease, predominantly secondary to HCV, has emerged as a leading cause of morbidity and mortality among HIV-infected IDUs. In 2007, UNAIDS estimated that the fastest growing HIV epidemics were in Eastern Europe and Central Asia - epidemics driven by drug use. India has ~2.4 million HIV-infected persons and is home to ~1.1 million IDUs with HIV prevalence ~30% and HCV prevalence ~60- 90%. As access to highly active antiretroviral therapy (HAART) has improved dramatically over the past few years, an epidemic of liver disease primarily associated with HCV seems inevitable among IDUs in India. The burden and impact of liver disease in India will likely differ from the US and Europe considering heavy underlying disease burden (e.g., TB, HBV), patterns of antiretroviral and anti-tuberculosis therapy (ATT) availability/use (primarily nevirapine [NVP]/stavudine [d4T]/rifampin-containing regimens) as well as the co- occurrence of factors associated with fatty liver (HCV genotype 3, d4T use, genetic predisposition to insulin resistance, heavy alcohol use). The interplay of these risk factors is likely to produce a unique phenotype of liver disease one that not only results in high levels of fibrosis but steatosis and potentially steatohepatitis. The availability of treatment for HCV remains limited in the developing world; however this disparity will change and will raise the urgency of understanding how exposures that occur more in India, like insulin resistance and treatment with hepatotoxic medications for HIV and TB, affect the prevalence and forms of liver disease and whether those at greatest liver disease risk can be identified with novel, culturally acceptable tools. Accordingly, our Specific Aims are: AIM 1: To ascertain the prevalence of fatty liver disease (e.g., steatosis, steatohepatitis) and investigate the hypothesis d4T use, HCV genotype 3, insulin resistance and alcohol use are independently associated AIM 1.1: To validate existing diagnostic algorithms for steatosis and fibrosis and to compare the predictive accuracy of existing panels (e.g., APRI, FIB-4) with new panels that use low-cost tests and local risk factors AIM 2: To determine whether steatosis and liver fibrosis impact the incidence of future hepatic adverse events associated with antiretroviral therapy and anti-tuberculosis therapy AIM 3: To begin to pilot interventions to reduce the burden of liver disease among IDUs in India. AIM 3.1. To quantify the acceptability and potential for HCV treatment response (prevalence of single nucleotide polymporphisms [SNPs] in the IL28b gene) among IDUs in India AIM 3.2. To conduct a double-blinded placebo controlled randomized clinical trial to determine the efficacy of Vitamin E for the treatment of steatosis The proposed study will characterize the burden and impact of liver disease in a population of IDUs in India and will begin to explore the impact of interventions to reduce the burden of liver disease. The study will be built on two existing IDU cohorts followed since 2005. Cohort members in follow-up (~500) will be recruited for a cross-sectional study of fatty liver disease (Aim 1); we will supplement to achieve a total sample size of 800. Using ultrasonagraphy to identify steatosis and Fibroscan(R) to characterize fibrosis, we will also validate and develop new diagnostic algorithms for liver steatosis and fibrosis. For Aim 2, we will enrich this cohort with persons with advanced liver disease to achieve ratios of: 1) 40% no fibrosis; 2) 35% mild/moderate fibrosis; and 3) 25% significant fibrosis. We will follow this cohort semi-annually to identify persons who initiate ART and ATT and conduct intensive follow-up with liver assessments after initiation of a new treatment regimen to determine hepatic tolerability. Finally, in Aim 3, we will assess acceptability of HCV treatment via questionnaire and potential for treatment response by performing host genetic testing. We will also conduct a randomized clinical trial of Vitamin E for the treatment of steatosis among 100 IDUs with evidence of moderate to severe steatosis at baseline. Response will be judged by liver biopsies performed pre- and at baseline and 96 weeks. Alcohol use and adherence will be assessed by use of text messaging during the trial. The research teams from JHU and YRGCARE are experienced in studying HIV and HCV and conducting cohort studies and clinical trials, having worked together since 1997. We have a small window of opportunity to prepare for the impending epidemic of liver disease among IDUs in the developing world and implement interventions before we start to observe a repeat of the pattern which has unfolded in the developed world.